PHASE II, RANDOMIZED TRIAL OF AMPRENAVIR AS PART OF DUAL PROTEASE INHIBITOR

The purpose of this study is to see how many any people will have an undetectable amount to HIV in the blood(less than 200 copies/ml) by week 24; see if these drugs are safe to take in combination and how well they are tlerated. This studyt will use the following anti-HIV drugs teh are FDA-approved: saquinavir (SQV), nelfinavir (NFV) adn indinavir (IDV). IN addition, the study will use amprenavir (APV) abacavir (ABC), adefovir dipivoxil ADV) and efavirenz (EFV). which are investigational anti-HIV drugs (not approved by the FDA.)